Defining Stat3 Antimicrobial Mechanisms in Human Urothelium

PROJECT SUMMARY/ABSTRACT
Urinary tract infections (UTI) are a morbid condition affecting a significant proportion of individuals; yet there has
been minimal progress made in their treatment and even prevention beyond antibiotic use. The host-pathogen
interaction is an important relationship in UTI pathogenesis and interventions promoting the host innate immune
response to reduce UTI susceptibility would be ideal therapeutic measures. The urothelium serves essential
roles in the detection and elimination of invading bacteria through expression of bacterial receptors, production
of cytokines and chemokines, and secretion of antimicrobial peptides (AMPs). We have previously demonstrated
in a murine model of UTI that the interleukin (IL)-6/Signal Transducer and Activator of Transcription (STAT) 3
signaling pathway in the urothelium is important in producing AMPs and eliminating uropathogenic Escherichia
coli (UPEC) from the urinary tract. While the transcription factor STAT3 is a central mediator in this process, its
contributions to urothelial antimicrobial properties and transcriptional targets are incompletely understood.
The objective of this proposal is to define STAT3 mediated host defense mechanisms in human urothelium. This
proposal tests the hypothesis that STAT3 and its downstream targets contribute to UTI defense by limiting
intracellular and extracellular bacteria urothelial reservoirs necessary for UTI pathogenesis, with the goal that
these host mediators could be leveraged in treating and preventing UTI. The novelty of this proposal is the use
of CRISPR/Cas9 gene editing in human urothelial cells to study STAT3 biology and the use of RNA-seq to reveal
transcriptional targets of STAT3 signaling. The anticipated outcome of this research is to identify the mechanisms
by which STAT3 confers host immunity against UTI and reveal its therapeutic targets. Aim 1 will define
mechanisms by which STAT3 mediates urothelial defense against UTI in human urothelial cell culture. Aim 2 will
identify transcriptional targets of STAT3 that serve instrumental roles in limiting UTI. Together, these Aims seek
to implicate STAT3 and its downstream targets as integral components of the host innate immune response to
UTI. The completion of this award will broaden our understanding of the mechanisms by which STAT3 signaling
impacts UTI and provide candidate transcriptional targets which would be further interrogated in an R01
application.

Public health relevance
PROJECT NARRATIVE Urinary tract infections (UTI) impact millions of individuals annually, with a much better understanding of host antimicrobial mechanisms required in order to yield much needed alternatives to antibiotics for UTI prevention and treatment. In this application, using gene editing and next-generation sequencing technology, I will test the hypothesis that the urothelial transcription factor, STAT3, and its downstream transcriptional targets contribute to UTI defense in human urothelium. Completion of the proposed aims will identify the mechanisms by which STAT3 confers host immunity against UTI and reveal STAT3 transcriptional targets to harness for future non- antibiotic based therapies.